The IL-18-IFNγ axis predicts response to immunotherapy

ABSTRACT
CAR T-cells have revolutionized the treatment of pediatric leukemia. However, ~50% of responsive patients
eventually relapse and in ~50-70% of patients, this therapy induces devastating side effects (i.e. neurotoxicity
(NTX) and cytokine release syndrome (CRS)), potentially leading to long term neurological damage and death.
There are no clinical biomarkers to predict survival or toxicity despite a crucial need. SCRI has made a substantial
investment in CAR T therapy and is a world leader in pediatric CAR T cell clinical trials. This proposed project
will build upon this program by helping to predict and mitigate the devastating, life-threatening side effects caused
by this revolutionary therapy and may aide in the prediction of non-response cases. Data from our pilot
experiments utilizing samples from patients on CAR-T trials at SCRI suggests that pre-monocyte activation
status and cytokine profiles from the monocyte fraction of a patient can predict CAR T toxicity across both blood
and solid tumors, in particular we see trends in the IL-18- IFN𝛾𝛾 axis. We plan to act on this encouraging pilot
data in this proposal to develop a series of validated monocytic biomarkers (cytokine, flow and transcriptional)
and machine learning algorithms which can be utilized prior to patients going on trial in order to save time and
resources for patients who are set to fail treatment and allow medical teams to be more prepared to mitigate
toxicity in those who are more prone to it. The proposal further expands to the development a humanized mouse
model that can adopt the healthy donor and pediatric patient immune systems recapturing natural variability in
human immunity to investigate causality of the IL-18- IFN𝛾𝛾 axis in driving both therapeutic toxicity. The project
combines existing but unused large bank of SCRI CAR T patient samples/data with monocytic omics profiling to
develop predictive biomarkers for therapeutic toxicity (AIM 1). We aim to further extend the impact of this work
to mechanistically understand why certain patients’ cells are working against them through the use of novel
humanized mouse models (AIM2). This is built upon to develop therapeutics or strategies to improve safety and
efficacy of CAR-T treatments. Importantly, our team of experts in clinical CAR T (Dr. Rebecca Gardner, Dr. Navin
Pinto), machine learning (Dr. Bobbie-Jo Webb-Robertson), humanized mice (Dr. James Keck), and myeloid
tumor biology (Dr. Heather Gustafson) pose this grant for optimal success.

Public health relevance
Project Narrative CAR T-cells have revolutionized the treatment of blood cancers, but 50% of responsive patients eventually relapse and in ~50-70% of patients, this therapy induces devastating side effects (i.e. neurotoxicity (NTX) and cytokine release syndrome (CRS)). By studying the pre-monocytic activation status and cytokine profiles from the monocyte fraction of a patient, this proposal will aim to validate that one can predict CAR T toxicity and efficacy. Through the use of a developed humanized mouse model we will investigate if this pre- inflammatory status is causative of toxicity outcomes.